MPROS- MOBILE PRO-CTCAE ADMINISTRATION SYSTEM FOR POST-RADIATION TOXICITIES

mPROS is a patient-centric smartphone app which allows patients to comfortably report symptoms that are due to radiation and chemo-radiation treatment. mPROS provides clinicians with access to patient information that can be used to make timely treatment adjustments. Ultimately, mPROS will be integrated into Electronic Health Record (EHR) systems to make it seamless for clinicians to access patient-reported outcomes. It is hypothesized this individualized symptom reporting will improve patient health-related quality of life (HRQOL). The primary objective of the Phase II study is to demonstrate this benefit. Phase II will refine and improve the user experience and the content in mPROS and then run a randomized clinical trial to test its validity by showing that timely and individualized symptom reporting can result in better patient HRQOL.